Effects of Resonance-Frequency Breathing on Preclinical Alzheimer’s Disease Biomarkers and Cognition

PROJECT SUMMARY
The cascade of brain changes involved in Alzheimer’s disease (AD) starts many years before diagnosis,
suggesting that earlier interventions will be more successful. Alzheimer’s tau pathology follows a predictable
path through the brain, starting with ‘pretangle’ tau in a small brainstem nucleus called the locus coeruleus
decades before any diagnosis. Despite its small size, the locus coeruleus controls many aspects of activity in
the brain and body. It is the brain’s arousal hub region, integrating all sorts of signals about arousal (e.g.,
wakefulness, emotion, novelty, stress) and shaping cortical activity to match current demands. Phasic bursts of
LC activity promote synaptic plasticity in the hippocampus and help make novel and emotional events
memorable. However, during periods of on-going stress or anxiety, the LC fires steadily (tonically), preventing
phasic bursts. LC activity patterns may also determine the impact of tau pathology. In rats with pretangle tau in
the LC, stimulating the LC steadily increases cell death while stimulating it intermittently reduces the memory
impairment and structural degeneration caused by pretangle tau. These findings in rats used invasive
procedures to stimulate the LC, but noninvasive methods, such as breathing, can also influence LC activity. In
the current R01 revision, we propose adding a task assessing LC responses to novelty to a stage II doubleblinded randomized trial with Black and White American adults aged 50-70 to test whether daily sessions
involving breathing at around the baroreflex frequency (~10 s per breath, known as resonance frequency
breathing) affects LC function. The baroreflex provides a negative feedback loop to maintain blood pressure at
nearly constant levels. Elevated blood pressure stretches mechanical baroreceptors in arterial walls which
signal the brainstem, causing the heart rate to decrease and blood vessels to dilate. As part of this feedback
loop, baroreceptor activity inhibits ongoing activity in the LC. Previous intervention studies have found that
regular sessions of resonance frequency breathing over the course of several weeks can reduce blood
pressure and improve baroreflex sensitivity. In the proposed study, we examine whether the practice can also
shift LC activity to a less tonic, more phasic, pattern. In our 10-week intervention, we will randomize
participants to either resonance-paced breathing or to a control breathing condition. We will have participants
do a task (both before and after the intervention) in which LC function is associated with tau pathology. The
task requires subjects to match faces to names. In this task, older adults exhibiting larger phasic responses to
novel face-name pairs show less tau pathology in the entorhinal cortex, one of the first places tau tangles
emerge when brainstem tau spreads to the cortex. We predict that the daily resonance frequency breathing will
downregulate tonic LC activity, allowing phasic LC signals to emerge more effectively. We predict that daily
resonance frequency breathing will improve LC phasic activity in both groups, but more so in Black than in
White Americans, given that initial findings suggest greater age-related LC decline in Blacks.

Public health relevance
PROJECT NARRATIVE Alzheimer’s tau pathology follows a predictable path through the brain, starting in a small brainstem nucleus called the locus coeruleus decades before any diagnosis. In this project, we test whether daily slow-paced breathing sessions can promote a healthy pattern of locus coeruleus activity in Black and White adults ages 50-70.